The Gut Brain Parkinson's Disease Consortium (GBPDC): Coordinating and Data Management Center (CDMC)

Parkinson's disease (PD) is an intractable disorder characterized by progressive loss of dopaminergic neurons
in the substantia nigra, resulting in tremor, rigidity, bradykinesia, and postural instability. By the time a clinical
diagnosis is confirmed, a considerable proportion of dopaminergic neurons have degenerated. Gastrointestinal
(GI) dysfunction may be an early manifestation of the disease and the gut may be an unexplored diagnostic
and/or therapeutic target. In response, the Gut Brain Parkinson's Disease Consortium (GBPDC) will build an
annotated repository of biospecimens to allow for the identification, development and validation of innovative
early-phase GI-based diagnostic tools and biomarkers for PD. To support the creation of this valuable resource,
we will develop a Coordinating and Data Management Center (CDMC) that addresses the resource sharing,
data science and analytical challenges unique to this consortium. Our team brings immediate expertise in key
areas of biorepository management, data science and analysis, combined with an operational structure and
guiding principles of the Duke Clinical Research Institute (DCRI). Our vision is to employ a team science
approach to establish an innovative, efficient, flexible, and metric driven CDMC designed to support the
establishment of the GBPDC biorepository and accelerate development of innovative early-phase GI-
based diagnostic tools and biomarkers for PD. To achieve our vision, we will establish a program framework
of three Cores: Research and Resources, Data Management, and Biorepository to execute the three main
CDMC functions outlined in our aims: 1) provide program leadership and expertise; assistance in study and
protocol design; and study implementation, monitoring, and management for GBPDC awardees; 2) support the
creation and maintenance of a harmonized GBPDC data and research ecosystem; facilitate compliant and
seamless data sharing and dissemination; 3) provide scientific and laboratory expertise and leadership to
coordinate the receipt, processing, storage, and distribution of biospecimens. The Cores will be supported by
the Web-based Activities and Dissemination Program Core that will ensure a rich research communication plan
to facilitate the sharing of resources with the internal consortium and broader scientific communities. Our
proposed CDMC will establish the required functions to efficiently support the establishment of the GBPDC
program with a focus on expanded reach, efficiency, and accelerated data analysis and result dissemination.
This program is possible because of the unparalleled breadth of complementary services and expertise offered
by our collaborative team.

Public health relevance
Gastrointestinal (GI) dysfunction may be an early manifestation of Parkinson's disease (PD), the second most common neurodegenerative disorder. The Gut Brain Parkinson's Disease Consortium (GBPDC) will support the establishment of the GBPDC biorepository and accelerate the development of innovative early-phase GI-based research tools and biomarkers for PD. Our proposed Clinical Data Management Center will establish the required infrastructure, data management, analytics, and resource-sharing functions to efficiently support the establishment of the program with a focus on expanded reach, efficiency, and accelerated data analysis and result dissemination.